Rapid Acquisition of the Frequency-Specific Auditory Brainstem Response Through Parallel Stimulus Presentation

Project Summary/Abstract
The auditory brainstem response (ABR) is an essential tool in diagnosing infant hearing loss, and its results
drive decisions regarding interventions and hearing habilitation with impacts extending far into a child’s future.
Despite the traditional ABR exam’s usefulness, there is an identified need to develop faster, more informative
exams. The overall goal of this proposal is to transform paradigms for ABR hearing assessment using
advanced stimulus design and signal processing tools. We have developed and validated in adults the parallel
ABR (pABR), which measures responses to all frequencies of interest in both ears all at once, rather than the
traditional series of single-frequency measurements in one ear at a time. The pABR provides waveforms and
estimates thresholds over twice as fast as serial ABR measurement and predicts hearing loss with very high
accuracy in adults. The pABR’s speed is critical, as diagnostic ABR exams are typically performed while an
infant sleeps, limiting their length to that of an unpredictable—and often short—nap. Aim 1 of this proposal is to
validate the accuracy of the pABR in infants by comparing it to current ABR methods. We will estimate hearing
thresholds using the pABR in young infants with hearing loss and compare them to measurements made with
standard serial ABR methods. In Aim 1a we will test air conduction thresholds. In Aim 1b we will test bone
conduction thresholds, which are critical for diagnosing conductive hearing loss. In Aim 2 we will measure
pABR thresholds in infants aged 8–14 months and compare them to gold standard behavioral thresholds using
visual response audiometry. We will also establish pABR-behavioral stimulus level conversion factors for both
air and bone conduction, allowing the pABR to be included in commercial devices and deployed in the clinic.
Aim 3 is to leverage a powerful denoising algorithm that we have developed to allow rapid collection of pABR
responses without the need to interactively guide the exam. In radiology and other fields, technicians perform
tests, freeing the expert to focus on making a diagnosis and consulting with the patient. With rapid, automatic
collection of all response waveforms—something never before possible—a technician could run the pABR test
and provide the results to an audiologist, potentially at another site, for later diagnosis and consultation. Such a
paradigm would open new avenues for healthcare delivery to rural, low-income, and other underserved areas.
We will test this tool in adults (Aim 3a) and then infants (Aim 3b) with hearing loss. The pABR is an innovative
paradigm that, combined with our advanced denoising tools, could lead to substantial improvements in hearing
loss diagnosis. These improvements will facilitate timely and accurate diagnosis that will impact thousands of
infants and families each year.

Public health relevance
Project Narrative The frequency-specific auditory brainstem response (ABR) is a diagnostic tool that is used to test for hearing loss in infants and provide treatments such as behavioral intervention or hearing aids. The ABR is performed while the infant sleeps, which leads to tests with unpredictable durations that are often too short to provide complete information. This project is relevant to public health because it will test a new, fast ABR exam called the parallel ABR (pABR) to determine its diagnostic accuracy in infants and its potential to enable more flexible testing that could increase access to underserved populations.